Cardiac Exosomes in myocardial Ischemic injury

PROJECT SUMMARY / ABSTRACT
Ischemic heart disease, the leading cause of mortality worldwide and at $475 billion/year also the costliest
disease in the US, is highly heritable. Ischemia initiates specific biological processes that are highly dependent
on genetic, transcriptional, and translational variation. In particular, regulation by noncoding RNAs (ncRNA),
crucial components in the human genome, play a significant role in the biology of myocytes undergoing
ischemia. Extracellular vesicles (EV) are emerging as new regulators of cell-to-cell communication carrying
biological information, including proteins, lipids, and ncRNAs. The ncRNAs contained in EV, namely
extracellular RNAs (exRNA), include microRNAs and other types of small RNAs and lncRNAs, some of which
have been shown to be regulated by stressors and mediate functional effects in their recipient cells. Thus,
exRNA offer tremendous potential as therapeutic molecules and biomarkers of disease.
We have built a unique human tissue sample bank of over 230 patients experiencing myocardial ischemia
while undergoing cardiac surgery with cardiopulmonary bypass (CPB). CPB is an applied human model of
ischemia, as it is associated with obligatory ischemic myocardial injury evidenced by cardiac biomarker
release, and therefore shares commonality with ambulatory myocardial infarction. Using this resource and as
part of our NHLBI award, in the past four years we examined mRNA differential expression, lncRNAs, and
microRNAs in ischemic human left ventricular myocardium, putting us in an ideal position to study the
significance of exRNA in myocardial ischemic injury.
We now propose to further explore the role of various short- and long ncRNAs by examining acute dynamic
changes in ncRNAs in response to ischemia. Therefore, we will characterize the ncRNA transcriptome in the
human and mouse heart, examine exRNA at various non-ischemic and ischemic time points in humans and
mice, test for expressed quantitative trait loci (eQTL), and validate in a large population of cardiac surgical
patients. Furthermore, we will use an ischemic mouse model to determine if the dynamically regulated exRNAs
are present specifically in cardiomyocyte-derived EVs which will provide the framework for future interventional
genetic studies.
The results of this study will define the link between genetic variation, altered ncRNA expression and
myocardial injury in human myocardial tissue and its associated ncRNA peripheral biomarkers. These ncRNA
biomarkers can have an immediate clinical impact and advance the biological understanding, diagnosis and
therapy of myocardial injury in humans.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of death and disability in the world, and with an aging population only expected to increase. Genetics play a significant role in the causes and outcomes of a heart attack, yet we know little about the etiology, pathways and modifiers of disease progression, nor do ideal biomarkers exist. Therefore, we are examining genetic effects of a mild heart attack on the left ventricle of the heart in mice and humans, and identifying markers in human and mouse plasma that can diagnose and treat the effects of the heart attack. Subsequently, we will verify these results in a much larger population of patients undergoing heart surgery.